BLRD RESEARCH CAREER SCIENTIST AWARD APPLICATION

The overarching goal of my research is to apply molecular neuroscience research to identify
better treatments for Veterans conditions for which there are currently no effective treatments.
Specifically, my work has focused on Alzheimer’s Disease (AD), Traumatic Brain Injury (TBI), Gulf
War Illness (GWI) and Posttraumatic Stress Disorder (PTSD). Primarily, I use mouse models of
these conditions, in order to explore the pathobiology of each condition over the mouse lifespan at the
behavioral, biochemical and pathological level, and therein identify key targets for potential
therapeutic intervention. Mouse models of AD, created using human AD-causing mutations
(including those which I discovered), are commercially available; the mouse models of TBI, GWI and
PTSD I have developed in-house. Using brain tissue and blood samples from these mice, we
investigate cellular and molecular level changes that correlate with behavioral and pathological
outcomes, in order to identify i) in the brain, potential molecular targets to intervene in the
pathobiological sequelae; and ii) in the blood, potential diagnostic and theragnostic signatures. I work
closely with many clinical collaborators to inform and direct the development and characterization of
these models and to ensure that they have clinical relevance, in order to facilitate translation into
clinical applications. This includes obtaining human blood and autopsied brain samples which can be
used to verify and validate findings from our mouse models. Neuroinflammatory and neuroimmune
mechanisms are emerging as key contributors in all of these conditions, but those umbrella terms
encompass a multitude of detail into which we are now delving, including cell-specific and timing-
specific responses.
One of the unique aspects of my research programs has been our attention to lifelong
consequences of the insults/exposures experienced in TBI, GWI or PTSD. These lengthy studies
have resulted in e.g. 1) characterization of the lifelong (27 months old) consequences of single and
repetitive mild TBI in mice aged 3 months at the time of injury – critically important data to understand
the chronic effects of neurotrauma and provide a platform for studies of potential therapeutics; 2)
characterization of the lifelong (25 months old) consequences of early life (3 months old) exposure to
agents known to be contributory to GWI – very important for the current patient population who are
suffering Today from GWI, more than 28 years after their toxic exposures; 3) demonstration of
behavioral, biochemical and pathological outcomes in our novel PTSD mouse model 6 months after
stress exposure –a translationally relevant preclinical platform in which to model our military and
veteran populations with persisting PTSD.
In these relevant laboratory models, we are identifying cell signaling pathways which, when
modulated, mitigate against the negative outcomes of these various exposures. In GWI we have
shown that the PPARa agonist, and dietary supplement, oleyoylethanolamide (OEA) is an effective
treatment in our model, and have advanced into a Phase II human trial of OEA (ongoing). We have
demonstrated that Nilvadipine (our lead anti-AD drug with anti-amyloid, anti-tau and anti-inflammatory
properties) and Anatabine (a potent NFkB inhibitor / anti-inflammatory agent, previously available as
a nutraceutical) each show positive outcomes in our mTBI models, including when administered at
delayed timepoints post-injury (again highly relevant to the human mTBI patient population). My goal
over the next ten years is to advance validated, well rationalized, novel treatments, derived from
these research studies, into human clinical trials for AD, TBI, GWI and PTSD.

Public health relevance
My research focuses on identification of novel, effective treatments for Veterans’ conditions that currently have no effective treatments, including Traumatic Brain Injury, Gulf War Illness and Posttraumatic Stress Disorder. These are currently typically addressed by attempted repurposing of existing drugs, rather than development of new drugs specifically targeting their underlying pathobiology. My team and I have developed mouse models of all of these conditions, which we then use to understand the molecular mechanisms causing the negative outcomes, working closely with clinicians, and clinical samples from patients, in order to be sure that our models are relevant to the human condition. We have been successful in advancing novel treatments for Alzheimer’s Disease and Gulf War Illness into clinical trials, and this experience provides a roadmap and informs my ongoing and future endeavors.